DETERMINANTS OF SODIUM RETENTION IN CIRRHOSIS

Prospective evaluation of liver function, systemic hemodynamics and plasma norepinephrine, renin, and ANF levels in patients with alcoholic cirrhosis as sodium balance spontaneously varies with alcoholism and abstinence.